Program Management Office Support Services (PMOSS)

The objective of this requirement is to acquire professional technical PMO program and project management, related consulting and support staffing, and services required for the efficient and effective operations of the CBIIT PMO and NCI programs and projects managed by CBIIT. Support shall be provided across the entire portfolio of CBIIT IT programs, projects, systems, services, and governance operations including input into and support of mandated Department of Health and Human Services (HHS) Enterprise Performance Life Cycle (EPLC) management, Federal Capital Planning and Investment Control (CPIC), and Federal Information Technology Acquisition Reform Act (FITARA) programs and processes. To be successful, the Contractor must provide staff with an in-depth knowledge of, and expertise in, IT, scientific and medical program and project coordination, and management. The Contractor must also possess proven, recent, and successful past experience in supporting and providing program, project, and PMO-related support and services in the rapidly changing biomedical informatics and research information system environment in organizations of similar size and complexity as the NCI CBIIT.